Neuro-computational predictors of treatment responsiveness in trauma-exposed Veterans.

While evidence-based treatments (EBTs) for PTSD are effective at reducing trauma-related anxiety
symptoms, about half to two thirds of trauma-exposed Veterans do not fully recover during treatment and
maintain their PTSD diagnosis. Anhedonia, i.e., a reduced interest and engagement in rewarding activities, is
prevalent in trauma-exposed Veterans and is associated with including higher PTSD severity and poorer
response to psychiatric treatment. Impaired reward sensitivity is therefore likely to play a critical role in
treatment responsiveness in Veterans. However, to date, the degree to which such altered reward sensitivity
impacts PTSD treatment responsiveness has not been tested. To test this hypothesis, the proposed study will
combine computational modeling and event-related functional magnetic resonance imaging (fMRI) to assay
reward processing function in Veterans at the end of Cognitive Processing Therapy (CPT), and test the
usefulness of such markers in predicting treatment responsiveness. Computational modeling, particularly in
concert with neuroimaging, provides detailed mechanistic insights into complex cognitive processes, which can
predict clinical outcomes more accurately than standard behavioral and neuroimaging analysis. We will
capitalize on this approach to delineate robust predictors of treatment response in trauma-exposed Veterans.
A total of 186 trauma-exposed Veterans will be recruited immediately upon enrolling in CPT. They will
complete a full clinical assessment and two multi-arm bandit (MAB) tasks (in classic and social conditions, to
be compared in exploratory analyses), in which they must choose on each trial from among a set of options
with unknown reward probabilities, with the goal of maximizing total rewards. Concurrent brain activity will be
measured in a subset of 93 Veterans who will complete the task while undergoing fMRI. A Bayesian learning
model will be applied to participants’ decisions to derive individual-level parameters representing a) individuals’
perceived stability of the unknown reward rates in the environment and b) the degree to which their model-
based expectations of reward influence their choices. Neural activation parametrically associated with trial-to-
trial model-based reward expectations and associated prediction errors (i.e., difference between expected and
observed reward) will be extracted. All participants will complete follow-up clinical and behavioral assessments
immediately after treatment and 3 months after treatment. Computational parameters and model-based neural
activations will be tested as predictors of pre- to post-treatment change in PTSD severity, controlling for pre-
treatment PTSD severity and relevant psychiatric comorbidities. This project aims to determine whether
computational markers of reward processing (Aim 1) and associated neural correlates of reward
anticipation (Aim 2) at the onset of EBT can be useful in predicting reduction in PTSD symptoms
among trauma-exposed Veterans. Aim 3 will assess whether such computational markers are
predictive of post-treatment outcomes 3 months after treatment. Treatment-related change in
computational markers of reward processing and their relationship to change in anhedonia and PTSD
severity will also be explored (Aim 4). The outcomes of this study will help to identify unmet treatment needs
in Veterans and develop treatment planning and relapse prevention tools for Veterans at risk for poor recovery
from PTSD. Identifying such predictive mechanisms will also provide critical neural and psychological targets
for developing more effective, personalized treatments to improve PTSD recovery (e.g., cognitive training to
boost reward sensitivity and decrease anhedonia).

Public health relevance
A majority of trauma-exposed Veterans continue to experience PTSD symptoms after evidence-based treatment (EBT). Anhedonia, i.e., reduced positive affect and reward responsiveness, is common in trauma- exposed Veterans, and impaired reward responsiveness has been implicated as a risk factor for developing PTSD and poor treatment response. The proposed research will use computational modeling and functional neuroimaging to identify individual markers of reward function and test the usefulness of such markers in predicting successful reduction of PTSD symptoms following EBT. By using a detailed mechanistic framework of reward processing, this research will help improve our understanding of PTSD complex clinical profile and to develop predictive tools to determine which trauma-exposed Veterans are at risk of poor EBT response. Results from this research may also help identify specific reward processing targets to develop adjunctive treatments to improve the effectiveness of psychological care for Veterans exposed to trauma.